Center Core Grant for Vision Research

PROJECT SUMMARY: OVERALL CENTER CORE
The overarching goal of the Center Core Grant for Vision Research is to support, strengthen and broaden
basic and translational vision science research at the University of Southern California. The Center Core will
provide shared resources accessible to a group of 28 outstanding investigators, dedicated to elucidating
mechanisms, diagnosis, and treatment of ocular diseases. Currently, these participating investigators
cumulatively hold 28 NIH-funded research grants, consisting of 21 grants from NEI (13 R01s, 1 R21, 7 K-
awards) and 7 grants from other institutes (4 R01s, 1 R21, 1 RF1, 1 K08). The Center Core will support 3
highly integrated Resource Cores: 1) Ophthalmic Therapeutics Engineering Core, 2) Cell & Tissue Imaging
and Data Science Core, 3) Animal Models and In Vivo Imaging Core. These Cores will offer exceptional
facilities, instrumentation and expertise that are essential resources to enhance and expand the research
programs of participating investigators, aid established investigators in pursuing research in new emerging
fields, and assist new investigators in developing vision research projects. The Center Core will also
coordinate and integrate Core activities, promote utilization of innovative emerging technologies, and facilitate
collaborative inter-disciplinary vision research. The Center Core will serve as a cornerstone for conduct of
impactful basic and translational vision research focused on advancing knowledge of the biology and
pathophysiology of the visual system and development of novel diagnostic and therapeutic approaches for
vision impairment.

Public health relevance
PROJECT NARRATIVE: OVERALL CENTER CORE The Center Core Grant for Vision Research will provide shared resources accessible to a group of independently-funded investigators to enhance their research capabilities and productivity. It will also create an environment conducive to collaborative scientific interactions and inter-disciplinary vision science research focused on advancing knowledge of the visual system and treatments for vision impairment.